New Directions in Palladium/Norbornene Cooperative-Renewal

Abstract: We are engaged in the systematic efforts to exploit new, efficient, and broadly useful
palladium/norbornene (Pd/NBE) catalysis for site-specific arene/heteroarene vicinal di-
functionalization and one-step carbonyl 1,2-transposition. Our objectives in the proposed funding
period include first to realize a previously unprecedented ortho oxygenation of aryl halides
enabled by a new class of electrophile; second to develop direct vicinal difunctionalization of five-
membered heteroarenes via both oxidative and redox-neutral approaches; and third to enable a
one-step carbonyl 1,2-transposition reaction. The proposed research is expected to identify new
synthetic methods and efficient catalyst systems, which should provide general and distinct
approaches to access poly-substituted arenes and heterocycles commonly found in
pharmaceuticals or to efficiently relocate carbonyl groups in complex molecules for generating
novel “functional group-shifted” analogues.

Public health relevance
Public Health Relevance Statement: Poly-substituted arenes and heteroarenes are ubiquitous in pharmaceuticals and approved drugs; however, the efficiency of using conventional approaches to access these structural motifs remains to be improved. The outlined proposal aims to enable new efficient catalytic methods for direct preparation of poly-substituted arenes and heteroarenes from readily available feedstocks. Success of the proposed research would significantly expedite the synthesis of complex aromatic molecules, which, in turn, would ultimately accelerate drug discovery.